Colorado Undergraduate Research in Environmental Health Sciences

? DESCRIPTION (provided by applicant): This grant application proposes a research and mentorship program for junior and senior undergraduate science students to enhance diversity in the environmental health sciences (EHS) based at the University of Colorado Anschutz Medical Campus. This program, the Colorado Undergraduate Research in Environmental Health Sciences (CUREHS), will draw students from the University of Colorado downtown Denver campus. It intends to expose students to research experiences and mentorship in the EHS for one year and will include an intensive summer program that trains them in the responsible conduct of research, and provides them with the confidence and guidance to pursue graduate education. Overall, the CUREHS Program will provide an integrated 3-pronged approach to developing student interest in environmental health research and careers: (1) Laboratory Experience; (2) Social/Community Development; (3) Educational/Inspirational Experiences. The goal will be to ultimately enhance diversity in the environmental health sciences by meeting the following aims: 1. Establish a research-training program for undergraduate students in the environmental health sciences; 2. Strengthen the undergraduate studies in the EHS at the University of Colorado Denver while improving the participants' preparedness for graduate or professional school and a career in the environmental health sciences; and 3. Enhance the diversity of students progressing to graduate or professional school in environmental health sciences.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project will recruit 6 undergraduate diversity students for research experiences and mentorship in environmental health sciences for one year and will include an intensive summer program focusing on laboratory experiences, mentoring, responsible conduct of research training and educational/inspirational experiences. Students will gain a better understanding of future career options and how to prepare for graduate or professional school with a long-range goal of increasing the number and quality of diversity students pursuing a career path in basic, translational or clinical environmental health sciences research.